Characterize multifaceted interactions between COVID-19 and alcohol use disorder based on real-time analysis of electronic health records of 62 million adult patients

PROJECT SUMMARY
During the pandemic, with social isolation and grief as drivers, alcohol consumption is increasing. SARS-CoV-2
itself has substantial impact on the central nervous system. When two such important public health menaces
intersect, it is crucial to understand their interaction and potential synergy. In this project titled “Characterize
multifaceted interactions between COVID-19 and alcohol use disorder based on real-time analysis of
electronic health records of 62 million adult patients”, we propose to: 1) characterize susceptibility to
COVID-19 in patients with alcohol use disorder (AUD) (“AUD → COVID-19”), consider racial and gender
disparity, and follow its evolution over time; 2) characterize how COVID-19 infection and the social pandemic
context impact the risk of AUD (“COVID-19 plus pandemic context → AUD”), consider racial and gender
disparity, and follow these changes over time; and 3) characterize prevalence of major psychiatric disorders,
other substance use disorders and severe outcomes among patients with both AUD and COVID-19
(“AUD+COVID-19 → outcomes”) and to follow these outcomes over time. Our studies will identify potential
areas for timely interventions to protect patients or mitigate the worst effects of COVID-19 pandemic and AUD,
singly and combined. This is especially important if there should be another surge with a virus variant, or if
vaccine hesitancy is greater in those with AUD. It will also inform such studies if we have another pandemic
with another organism, for the approaches we pioneer in these studies using nation-wide database of
electronic health records may pave the way for rapid, real-time analytics and results to inform our control
measures.

Public health relevance
PROJECT NARRATIVE We propose to characterize multifaceted interactions between COVID-19 and alcohol use disorder (AUD) based on real-time analysis of electronic health records of 62 million adult patients. Our studies can identify potential areas for timely interventions to protect patients or mitigate the worst effects of COVID-19 pandemic and AUD, singly and combined. It will also inform such studies if we have another pandemic with another organism, for the approaches we pioneer in these studies using nation-wide database of de-identified electronic health records may pave the way for rapid, real-time analytics and results to inform our control measures.